Shared Resource Management

Duke Cancer Institute (DCI) Shared Resources are instrumental to supporting and augmenting the innovation and impact of DCI’s entire research portfolio. The DCI supports 12 shared resources (SR) that meet the specific cancer research needs of our members across all seven research programs. These SRs promote the DCI’s Discover, Develop and Deliver mission and the specific research-focused strategic goals of the DCI Strategic Plan (2022-2027). The SRs provide prioritized services to DCI members and are continuously and proactively engaged in horizon scanning to provide our members with access to the most advanced technologies. DCI SRs support the full continuum of basic, translational, clinical and both patient- and catchment area focused population level cancer research including survey design and implementation. Each SR is led by world-class experts and provides extensive and comprehensive services including technical consulting in experimental design, processing and running samples, and data management and interpretation. DCI shared resources support all three aspects of the DCI mission; Discover: new targets and pathways via unbiased as well as targeted genomic, transcriptomic, proteomic, metabolic, and/or genetic research; Develop: biological models and technologies for moving discoveries into the translational pipeline including novel targets and pathways or conversely, undertake developmental research informed by the clinic or community; Deliver: cancer research findings from the discovery and/or development phases to the clinic and community through collaborative interactions with DCI’s patient and/or community facing Research Programs, Disease Groups, Community Outreach and Engagement and clinical trials pipeline. All the shared resources are available to DCI members throughout the entire translational research continuum and are utilized extensively by all of DCIs Research Programs. The 12 DCI shared resources provide preferred access and/or reduced cost to our DCI investigators. DCI’s extensive research portfolio requires multiple shared resources to be flexible in continuously evolving scientific scope and also be stable in operations and quality of their services. DCI’s SR management and oversight, under the leadership of the DCI AD for Basic Science, Christopher Counter, PhD (CRDI), the DCI Chief Data Officer Warren Kibbe, PhD (PCMIT) and the DCI AD for Administration Chloe Fournier, have set a structure which delivers services, allows for timely feedback, responsive actions to critiques, and keeps pace with technological and computational advances.
DCI SRs support the full continuum of basic, translational, clinical and both patient- and catchment areafocused population level cancer research including survey design and implementation. Each SR is led by world-class experts and provides extensive and comprehensive services including technical consulting in experimental design, processing and running samples, and data management and interpretation. DCI shared resources support all three aspects of the DCI mission; Discover: new targets and pathways via unbiased as well as targeted genomic, transcriptomic, proteomic, metabolic, and/or genetic research; Develop: biological models and technologies for moving discoveries into the translational pipeline including novel targets and pathways or conversely, undertake developmental research informed by the clinic or community; Deliver: cancer research findings from the discovery and/or development phases to the clinic and community through collaborative interactions with DCI’s patient and/or community facing Research Programs, Disease Groups, Community Outreach and Engagement and clinical trials pipeline.

All the shared resources are available to DCI members throughout the entire translational research continuum and are utilized extensively by all of DCIs Research Programs. The 12 DCI shared resources provide preferred access and/or reduced cost to our DCI investigators.

DCI’s extensive research portfolio requires multiple shared resources to be flexible in continuously evolving scientific scope and also be stable in operations and quality of their services. DCI’s SR management and oversight, under the leadership of the DCI AD for Basic Science, Christopher Counter, PhD (CRDI), the DCI Chief Data Officer Warren Kibbe, PhD (PCMIT) and the DCI AD for Administration Chloe Fournier, have set a structure which delivers services, allows for timely feedback, responsive actions to critiques, and keeps pace with technological and computational advances.